PRIMER: Promoting Research In MEdical Residency

Most residents view research during training favorably, yet few engage actively in research due to several barriers to pursuing a physician-scientist career. The Boston University-Boston Medical Center (BU-BMC) Multi-Disciplinary Program for Promoting Research In MEdical Residency (PRIMER) targets barriers, leverages BU’s renowned institutional strengths in heart, lung, blood and sleep (HLBS) research, and expands our research training for internal medicine residents substantially. This application represents a renewal of our highly successful residency research training (StARR) program. Our central objective is to provide a comprehensive ~2-year (contiguous 22 months with 80% protected research time, i.e., 17.6 months of 100% protected research time) training for medicine residents to pursue research in HLBS diseases, while ensuring their clinical board eligibility, and transition to a K38 award and a clinical fellowship.
Our programmatic goals are to: (1) train 2 medicine residents every year over a 4-year period in one of four cutting-edge HLBS research tracks, i.e., clinical epidemiology and translational research; genomics, computational biology and bioinformatics; health systems research and implementation science; and regenerative medicine, catering to both those with limited or advanced prior research training; (2) transition trainees to a K38 award as part of a post-R38 clinical fellowship.
To achieve these goals, we offer the following specific aims (outcomes/milestones are underlined):
(1) Provide broad transdisciplinary competency-based training in approaches to HLBS research to a PGY3 and a PGY4 resident every year, catering to both those with limited and substantial previous research experience. We will enable attainment of core competencies including communication skills, grant writing, responsible conduct of research, study design, analysis and interpretation, and leadership and team science.
(2) Feature personalized and mentored research projects for each trainee under the direction of an established NIH- or NSF-funded investigator in one of the four HLBS training tracks resulting in excellent scholarship.
(3) Provide authentic career mentorship using an individualized development plan and ongoing assessment to facilitate transition to board eligibility in internal medicine, a K38 award, and a clinical HLBS fellowship.
(4) Afford strong developmental support to recruit and retain trainees.
(5) Evaluate PRIMER processes and monitor outcomes continuously with summative and formative activities.
PRIMER integrates program directors with complementary skills, a group mentoring approach with ‘trained’ research and career mentors, opportunities for training and scholarship in four HLBS training tracks, an outstanding institutional environment that supports research, career and professional development of trainees, a rigorous competency-based learner-centered curriculum.

Public health relevance
Modified Specific Aims Section Most medical residents view research during training favorably, yet few engage actively in research due to numerous barriers to pursuing a physician-scientist (PS) career. The Boston University-Boston Medical Center (BU-BMC) multidisciplinary program for Promoting Research In MEdical Residency (PRIMER) targets these barriers, leverages BU’s renowned institutional strengths in heart, lung, blood and sleep (HLBS) research, and uses effective training methods and strong institutional support to substantially expand research training for internal medicine residents. This application represents a renewal of our highly successful residency research training (StARR) program, which provides comprehensive mentored research training over 22 contiguous months (divided into 10 months in PGY3 and 12 months in PGY4 with 80% protected research time, equivalent to 17.6 contiguous months of research) to selected BU-BMC internal medicine residents, while also ensuring clinical training requirements, board eligibility, and transition to a post-R38 HLBS clinical fellowship. In the first 3 years of PRIMER, we have enrolled 6 scholars (2 graduated, 1 each PGY3/PGY4 trainee, 2 accepted trainees). Trainees have collectively published 16 research manuscripts working with dedicated and experienced mentors across 4 innovative research tracks. We achieved program and scholar learning outcomes set forth in the 1st award period and established strong institutional infrastructure to foster continued success of PRIMER. For this renewal application, our overarching programmatic goals are to: (1) Train 2 residents every year (1 each in PGY3 and PGY4), choosing 1 of 4 HLBS research tracks: clinical cardiovascular epidemiology and translational research; genomics, computational biology and bioinformatics; health systems research and implementation science; and regenerative medicine. (2) Provide career and professional developmental support to R38 trainees to ensure board eligibility and transition to a HLBS fellowship with a K38 award. To achieve these programmatic goals, we offer the following Specific Aims (outcomes are underlined): (1) Provide rigorous multidisciplinary competency-based education to selected residents. We propose a non-degree curriculum that includes cross-track educational activities to develop foundational, functional, and superordinate skills in research design and methodology; career, professional and leadership development; ethical conduct of research; and additional track-specific courses mapped to the 4 training tracks. (2) Feature carefully planned and personalized mentored research projects for each trainee—under the direction of an established NIH- or NSF-funded investigator with expertise in 1 of the 4 training tracks—resulting in scholarship, presentation at national meetings, and peer-reviewed publications. (3) Impart authentic robust career mentorship using an individualized development plan (IDP) to ensure board eligibility in medicine, and to facilitate transition to a clinical HLBS fellowship with a K38 award after residency. (4) Afford strong developmental support to recruit and retain trainees. (5) Evaluate PRIMER processes and monitor outcomes continuously with summative and formative activities. Key programmatic milestones include: 1. developing core competencies in first year; 2. enhanced track-specific competencies and scientific presentations and publication(s) in both years; 3. ABIM certification; and 4. K38 grant and HLBS fellowship at the end of second year. BU-BMC created additional PGY2 slots to mitigate the impact of the R38 program on the clinical load of remaining residents and a unique Resident Research Scholar position (PGY4; equivalent of clinical chief resident), indicating strong institutional commitment. PRIMER integrates: R38 PIs with complementary skills in education, patient-oriented research and mentoring; a governance and oversight structure with external advisory and internal executive committees; a group mentoring approach by a well-funded trained team of research and career mentors, with additional peer and near-peer mentoring components; opportunities for rigorous scientific scholarship in stellar HLBS research training tracks led by established well-funded investigators while ensuring ABIM certification; robust evaluation assuring continuous quality improvement; an outstanding training environment with strong institutional commitment including a “mentor training” program; a “research hungry” resident pool working in a safety-net hospital serving an underprivileged multi-ethnic inner city community; innovative forward-looking competency-based, learner-centered, multidisciplinary curriculum with emphasis on experiential learning; novel technological platforms for off-campus online resident education; journal and IRB internships; a new Resident Research Scholar position; personalized training for residents based on their prior research experience; and exceptional career developmental support for future fellowship training. In the next award period, we will continue to recruit, train, and retain a diverse and talented cadre of resident investigators who will transition to K38 awards in their clinical fellowships, and become excellent physician-scientists focused on HLBS disorders. Modified Public Health Relevance Section The Boston University-Boston Medical Center (BU-BMC) Multi-Disciplinary Program for Promoting Research In MEdical Residency (PRIMER) will provide comprehensive ~2-year (contiguous 22 months of protected research time at 80% effort; 17.6 months of exclusive research time) transdisciplinary training for two internal medicine residents every year for the duration of the grant to pursue research in heart, lung, blood and sleep (HLBS) diseases, while ensuring their clinical training and medicine board eligibility, and transition to a K38 award as part of a clinical HLBS fellowship. The goals of PRIMER include mentored research under the guidance of a well-funded senior BU-BMC faculty member in one of four HLBS training tracks, career guidance by a senior mentor, professional development, and acquisition of key competencies for clinical research.